PROTEASOMAL REGULATION AND PROTEIN QUALITY CONTROL IN M. TUBERCULOSIS

Tuberculosis kills nearly 2 million people globally every year. Over the years, we have determined that the
Mycobacterium tuberculosis (Mtb) proteasome is essential to allow the tubercle bacilli to persist in animals.
Proteasomes are multi-subunit, barrel shaped proteases that degrade proteins in a highly regulated manner.
We are currently examining how proteolysis is regulated, from how proteins are tagged with the only known
bacterial protein-on-protein post-translational modification to how those tagged proteins are then delivered into
the proteasome core protease. Secondly, this proposal will seek to understand the functions of an essential
protein quality control system that is regulated by proteasomal degradation. Identifying how this system
contributes to Mtb physiology may identify new ways to combat tuberculosis infections. Thus, these studies will
reveal how a proteasome senses extracellular signals to optimize bacterial growth required for lethal infections.

Public health relevance
Tuberculosis kills nearly 2 million people annually. Tuberculosis therapy takes 6-9 months, a problem that leads to decreased compliance for taking antibiotics and increased chances of developing drug-resistance. The rise of extensively drug resistant (XDR) strains of M. tuberculosis is a public concern, thus the identification of specific pathways in Mycobacterium tuberculosis that could be targeted by new drugs is of great interest.